2023 Cilia, Mucus and Mucociliary Interactions GRC & GRS

PROJECT SUMMARY
This application seeks support for a Gordon Research Conference (GRC) and corresponding Gordon Research
Seminar (GRS) on Cilia, Mucus and Mucociliary Interactions from February 18-24, 2023 in Barga, Italy. This is
a highly integrated and unique meeting that unites basic scientists, bioengineers, translational investigators, and
clinicians who study the components and fundamentals of cilia and mucus biology, their interface as a
mucociliary apparatus, and human diseases related mucociliary dysfunction. Mucociliary clearance (MCC) is
essential for respiratory tract defense against inhaled pathogens. MCC dysfunction leads to infections and to
complications in asthma, rhinosinusitus, chronic obstructive lung disease (COPD), idiopathic pulmonary fibrosis
(IPF), cystic fibrosis (CF), and primary ciliary dyskinesia (PCD). Advancing technologies have led to growing
knowledge of the assembly and function of cilia, the production and secretion of mucin glycoproteins, and the
cilia-mucus interactions required for MCC. These innovations stem from the on-going work of established teams
and new entrants, including young investigators. Thus, an important element of this meeting is promoting
trainees and young investigators and involving women and minorities in alignment with missions of the GRC and
the NIH. This GRS/GRC meeting will lay foundations and provide new ideas for current and emerging leaders
in the mucociliary biology. A cohesive program is proposed to enhance the interplay between specialized
disciplines that seek to integrate knowledge and impact advances in biochemistry, biophysics, cell biology,
development, genetics, and translational research of common respiratory tract diseases. To enhance the
educational strength of the meeting, trainees will be invited to participate in a GRS, to present oral summaries
of their posters during morning lecture blocks, and in some cases give 10 min talks during the GRC meeting.
The GRS and GRC leadership teams have the shared goal of fostering an innovative, informative, and integrated
forum for discussing novel research and current challenges in mucociliary biology. The conference will
emphasize the following scientific themes: a) genetic and gene regulatory mechanisms of mucociliary
components, b) structure and function of mucin glycoprotein polymers and motile cilia, c) secretion of mucins
and mechanics of ciliary activity, d) the effects of mucociliary function and dysfunction on host physiology and
pathophysiology, and e) the on-going application of cilia and mucus biology to develop promote respiratory health
and reduce the burden of disease. With this approach, we seek to achieve three Specific Aims: 1) To
disseminate, discuss, and integrate the latest, unpublished, cutting-edge data on cilia, mucus and mucociliary
interactions in a forum of world experts and early career scientists; 2) to provide a platform that links fundamental
scientific knowledge related to cilia, mucus, and mucociliary interactions to human disease and avenues for
diagnosis and therapies; and 3) to facilitate and promote the involvement and advancement of underrepresented
minorities, women, and trainees in the study of cilia, mucus and mucociliary interactions.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) This unique, multidisciplinary conference brings together world experts to discuss the very latest research related to the biology and clinical aspects of mucus and cilia, hair-like structures on the surface of airway epithelial cells, as well as their interactions to create effective mucociliary clearance. The overarching goal of this meeting is to provide an opportunity for senior scientists in the field to interact with junior, female, and underrepresented minority scientists, facilitating the discussion of the genetic, developmental, and diagnostic features of respiratory tract diseases in children and adults (such as asthma, chronic bronchitis, cystic fibrosis and the genetic cilia disease primary ciliary dyskinesia), leading the way to new treatments. Additionally, in the era of the SARS-CoV2 pandemic, the expertise in airway biology and host-pathogen interactions of this GRC's audience offers a unique environment conducive to collaborations and solutions for this global challenge.